RADx Innovation Funnel for Hepatitis B Diagnostics - Coordination Center

The National Institutes of Health (NIH) Rapid Acceleration of Diagnostics (RADx®) Tech program was established to accelerate regulatory review and availability of high-quality, accurate, and reliable diagnostic tests. This project will generate evidence to support development of point-of-care diagnostic technologies for Hepatitis B (HBV).